Advancing Understanding and Measurement of Infertility, Related Fears and Stigma, and Associated Consequences in Low-Resource Countries

PROJECT SUMMARY
The project summary is as originally proposed.

Public health relevance
PROJECT NARRATIVE The project narrative is as originally proposed.